HIPK1: a new immunomodulatory target for SLE

ABSTRACT
Our prior work using physical maps of systemic lupus erythematosus (SLE)-associated genetic variation in the
context of the 3D structure of the genome in the nucleus of disease-relevant immune cell types have implicated
the kinase HIPK1 as a factor controlling SLE susceptibility. This kinase has been studied in the context of cancer,
but a role for HIPK1 in immunity, tolerance, or SLE has not been explored. In this exploratory, high-risk/high-
impact application we will use genetic and pharmacologic targeting approaches to establish whether HIPK1
regulates T cell differentiation, T cell-dependent humoral immune responses, and SLE pathophysiology in
powerful human and mouse models of follicular lymphocyte differentiation and function. The outcome of these
studies is likely to forward basic understanding of the regulation of humoral immunity and suggest a completely
novel immunomodulatory approach for the management of SLE disease.

Public health relevance
NARRATIVE The autoimmune disorder systemic lupus erythematosus (SLE) affects as many as 1.5 million Americans, the majority of which are young women of color, and available treatments do not effectively control SLE morbidity and mortality. SLE is inherited, and we have used a combination of genetics and functional studies to identify HIPK1, an enzyme previously studied in the context of cancer, as a potential regulator of lupus susceptibility. The work proposed will establish decisively whether HIPK1 is involved in the development of SLE, and whether drugs that modulate HIPK1 activity represent a new therapeutic approach for management of this significant human health problem.